Fragile X Premutations, Mechanisms and Modifiers

Overall Abstract:
Fragile X-associated Conditions (FXaCs) are a heterogeneous group of disorders arising from alterations in the
size and epigenetic state of a polymorphic CGG repeat within FMR1. Described as the first repeat expansion
disorder over 30 years ago, FMR1 CGG repeat expansions cause neurological, reproductive, and
neurodevelopmental diseases while also serving as an archetype for understanding repeat expansions and the
mechanisms by which they elicit dysfunction. Work over decades delineated the native functions of the fragile
X protein, FMRP, and the consequences of its loss and identified toxic gain-of-function mechanisms (DNA
toxicity induced by R-loop formation, RNA toxicity mediated by protein sequestration, and protein mediated
toxicity from Repeat associated non-AUG (RAN) translation) elicited by transcribed CGG repeats. Despite
these advances, we lack effective therapies for any FXaC – at least in part due to the enigmatic clinical
heterogeneity and incomplete penetrance of FxaCs that confound targeted approaches. Here we propose a
change in our approach to FXaCs. Rather than focusing solely on specific diseases (Fragile X Syndrome
(FXS), fragile X-associated tremor/ataxia syndrome (FXTAS), or fragile X-associated primary ovarian
insufficiency (FXPOI)), the Center structure enables us to directly engage the mechanistic crosstalk between
conditions and between the FMR1 locus and related repeat expansion disorders. Our central hypothesis is that
a deeper understanding of genetic, pathologic, and environmental factors which underlie the variable clinical
manifestations of premutation (PM)-associated disorders will reveal novel insights into both how repeats cause
disease and how we can target them therapeutically. We will address this hypothesis in three highly integrated
projects all focused on premutation disorders. These projects will use data-driven genomic and bioinformatics
approaches coupled with emerging tools and multiple model systems. Our outstanding team of experts from
four leading sites of Fragile X research features both junior and senior investigators and runs the gamut from
clinicians to neuroscientists to geneticists to reproductive biology experts. By pooling our substantial data,
expertise and resources, we will pursue identification of novel pathogenic mechanisms in FX premutation
disorders and develop a series of robust and viable targets and approaches for therapeutic development in
FXaCs.

Public health relevance
Overall Project Narrative: Repeating sequences within the DNA of FMR1, variably cause a set of human diseases (Fragile X Syndrome, Fragile X associated Tremor Ataxia Syndrome, and Fragile X primary ovarian insufficiency) for which we have no effective treatments. Our expert group will investigate the mechanisms by which this repeat causes disease while also identifying genes that modify the expressivity of Fragile X associated conditions. By using an integrative methodology that spans from patient derived samples, bioinformatic approaches and clinical symptoms to rodent and human neuronal models of disease, we seek to understand how repeats elicit dysfunction with a goal of developing a more effective approach to therapy development in Fragile X associated conditions.